Data Archiving A Longitudinal Cohort: Toledo Adolescent Relationships Study

ABSTRACT
The continual uncertainty of the COVID-19 pandemic, including the reality that there is no end in sight, has
disrupted the lives of adults and children. Conducting rigorous causal analyses of health and well-being
trajectories is hampered by social scientists’ lack of access to population-based longitudinal data collected prior
to and during the pandemic. Although there have been many new cross-sectional data collections initiated during
the pandemic, there are only a few cohort population-based collections that both situate individuals within their
social networks throughout the life course and include measures specifically linked to the pandemic and social
ties. The Toledo Adolescent Relationships Study (TARS) interviewed adolescents (mean age 15) and a
parent/caregiver in 2000 and conducted six subsequent interviews reaching into middle adulthood during the
pandemic (mean age 34 in June-November 2020). The initial sample of 1,316 respondents was drawn from
school rosters in Lucas County, Ohio (8 school districts). The comparative advantage of the TARS is the unique
and continual focus on social relationships (parents, partners, peers, other family, children) as well as inclusion
of indicators of key life course transitions (education, employment, family formation), contextual or geospatial
data, mental and physical health indicators, behavioral outcomes (e.g., substance use, criminal justice
exposure). Most domains include subjective as well as objective measures (e.g., perceptions of future
employment prospects and current employment status). The combination of rich data that predates the pandemic
and the most recent interview wave focusing on social distancing, pandemic stresses, coping, and subjective
well-being provides opportunities for research on variation in responses and adaptations to the pandemic.
Partnering with the international leaders in data stewardship, Inter-university Consortium for Political and Social
Research (ICPSR), will make possible a state of the art secure and virtual data enclave. Making these data
available at no charge through the ICPSR Data Sharing for Demographic Research (DSDR) will provide new
opportunities for researchers to answer critical questions about life course determinants of health and well-being
trajectories of men and women from adolescence into midlife. The three specific aims are to 1) Generate user-
friendly longitudinal, parent and geospatial TARS data file documentation; 2) Deposit longitudinal, parent, and
geospatial data and documentation files to DSDR for curation and availability through the ICPSR Virtual Data
Enclave; 3) Disseminate information about the availability of the TARS data through the secure ICPSR Virtual
Data Enclave. Our documentation, archiving and dissemination plans will ensure wide access to the data that is
cost-effective via a virtual portal to a broad range of social science scientists including researchers in criminology,
demography, economics, family studies, human development, public health, psychology, and sociology.

Public health relevance
PROJECT NARRATIVE Archiving and disseminating the Toledo Adolescent Relationships Study (TARS) aligns with the mission of NICHD to “support cutting-edge research to help improve the health of children, adults, families and communities.” The TARS is one of the few U.S. longitudinal (from adolescence into middle adulthood), population-based data sets available to assess health and well-being trajectories both prior-to and during recent public health and economic crises. We will work with Dating Sharing for Demographic Research to make a new TARS longitudinal data file available through a virtual secure data enclave and launch a dissemination plan to ensure that researchers from a range of fields, such as criminology, demography, economics, family studies, human development, public health, psychology, and sociology have access to valuable data that will provide answers to critical questions about variation in responses and adoptions to recent crises.